Work Assignment SUPS2.020.19.62, AHS Disease Validation

To conduct an autoimmune disease validation study among members of the Agricultural Health Study to validate self-reported Rheumatoid Arthritis, Systemic Lupus Erythematosus and Sjorgren[unreadable]s Syndrome.